Waisman Center Intellectual and Developmental Disabilities Research Center

We seek continued support of the Waisman Center Intellectual and Developmental Disabilities Research Center,
a comprehensive interdisciplinary program focused on IDD spanning the biological, behavioral, and biomedical
sciences. The Waisman IDDRC brings together 60 PIs from 24 academic departments from the UW-Madison’s
Schools of Medicine and Public Health, Veterinary Medicine, Agriculture and Life Sciences, Letters and Science,
Education, Engineering, Social Work, and Human Ecology. This application requests support for an
Administrative Core (Core A), providing scientific leadership, program and faculty development, facilitation of
interdisciplinary collaboration, oversight of training programs, biostatistical and bioinformatics expertise; and
dissemination of knowledges and best practices; and three innovative scientific core services: Clinical
Translational (Core B), providing services, resources, and training in the recruitment of human participants,
clinical research coordination/navigation, clinical assessment, behavioral methods development, and production
of clinical grade biotherapeutics for use in clinical trials; Brain Imaging (Core C), providing access to state-of-
the-art neuroimaging instrumentation for both human and animal studies (3T MRI, PET, and microPET scanners
for human, non-human primate, and rodent scanning, an fNIRS, and an EEG recording system), as well as
expertise and tools for image acquisition and analysis; and IDD Models (Core D), providing resources, expertise,
and technical services in cellular and molecular neuroscience, the generation and manipulation of human
pluripotent stem cell (hPSC) lines from humans with IDD conditions, as well as the generation and behavioral
phenotyping of mutant or genetically engineered strains of mice and rats as models of IDD conditions. In addition,
we request support for a Research Project that addresses a fundamental question on the emergence of ADHD
symptoms in children with ASD, using a multidisciplinary approach that combines the power of neurobehavioral,
brain imaging, statistical genomics, and machine learning analyses.
We propose to provide core support to 69 research projects headed by 44 PIs addressing three broad themes
relevant to IDD: 1) neurodevelopment and mechanisms, 2) disorders of the nervous system, and 3) assessments
and interventions. Collectively the core services and the research project of the Waisman Center IDDRC will
stimulate new interdisciplinary IDD research and enhance existing IDD investigations, with a sharp focus on
discovery, prevention, and treatment for IDD conditions, and improvement of the quality of life of individuals with
IDD and their families.

Public health relevance
PROJECT NARRATIVE The mission of the Waisman Center IDDRC at the University of Wisconsin-Madison is to promote the highest level of IDD research by providing access to cutting-edge and cost-effective core services, seminars, and pre- and post-doctoral training, via a comprehensive program designed to produce a transformative understanding of IDD pathology, development of new interventions, and training the next generation of basic and clinical IDD researchers.